Modeling Ion Selectivity in EF-hand Proteins

Project Summary/Abstract
Metal ions play crucial roles in numerous vital biological processes, encompassing muscle contraction,
respiration, photosynthesis, signal transduction, enzyme catalysis, and hormone secretion. It is estimated that
approximately 40% of proteins rely on metal ions for their functionality. Among the roughly two dozen biologically
available metal ions, precise ion selection is paramount, as incorrect ion binding can lead to reduced efﬁciency
and toxicity. However, our understanding of ion selectivity in many proteins remains limited. Molecular dynamics
(MD) simulations have emerged as an important tool in biochemistry research, offering atomic-level insights into
the fundamental mechanisms governing biomolecular function. However, accurate force ﬁeld models are
imperative for meaningful MD simulation results. Modeling metal ion-ligand interactions is challenging due to the
involvement of polarization and charge transfer effects. A key goal of this proposal is to establish a multiscale
modeling strategy to simulate ion selectivity in proteins. The Li research group has developed novel force ﬁelds
that efﬁciently and accurately capture the polarization and charge transfer effects in protein-ion systems. By
utilizing these force ﬁelds, which are parameterized from high-level quantum mechanical calculations, MD
simulations will be conducted to provide structural and dynamic insights into protein-ion interactions. Furthermore,
free energy simulations will be employed to unveil thermodynamic insights and identify key residues and factors
inﬂuencing ion binding afﬁnity. Enhanced-sampling simulations will also be employed to extract kinetic properties
of ion binding. These simulation results will be compared with existing experimental data or results obtained
through collaboration with experimental researchers, with the fundamental factors dictating ion selectivity will be
analyzed based on a comprehensive perspective. Ultimately, our proposal's central objective is to apply this
modeling strategy to investigate ion selectivity in EF-hand containing proteins, which are widespread in various
organisms and display remarkable and distinctive ion selectivity proﬁles. EF-hand motifs exhibit the capacity to
bind to diverse metal ions with varying afﬁnities. However, the mechanisms governing this selectivity remain
incompletely understood. We will focus on four EF-hand containing proteins: Calmodulin (CaM), Lanmodulin
(LanM), Troponin C (TnC), and Lanthanide binding tags (LBT), exploring their interactions with various metal
ions. Our research will elucidate the roles of ions, ligands, protein conformational dynamics, and solvents in
determining ion selectivity. The insights gained regarding how these proteins regulate ion selectivity will facilitate
the design of proteins with tailored ion selectivity and have implications for relevant drug design efforts.

Public health relevance
Project Narrative This project endeavors to elucidate the factors that dictate ion selectivity in proteins, providing fundamental insights into various biomolecules crucial to life processes. The central focus will be on advancing our understanding of ion selectivity within EF-hand containing proteins, which are widely distributed in organisms and known for their remarkable and distinct ion selectivity patterns. The comprehensive insights derived from this research have the potential to inform and guide relevant protein engineering and drug design efforts.